Genomically informed agent selection and testing in osteosarcoma patient-derived xenograft models

Project Summary/ Abstract
Survival outcomes for patients with osteosarcoma have not changed since the advent of modern chemotherapy
four decades ago and it has been challenging to develop new effective therapies in this disease. Our lab’s long-
term mission is to identify novel molecular targets in osteosarcoma via comprehensive genomic and proteomic
profiling of patient-derived cell lines and xenografts as well as human tumors with the ultimate goal of identifying
and/or developing and testing therapeutics against these targets. To achieve this goal, we have a) built a robust
profiling platform to identify novel targets; b) expanded our repertoire of osteosarcoma patient derived xenograft
(PDX) models to reflect disease heterogeneity; and c) conducted high-throughput in vivo testing of 8-10 new
agents each year both as part of Pediatric Preclinical Testing Consortium (PPTC) as well as independent of it.
All of these efforts form the basis of our current research proposal and place us strongly poised to successfully
achieve our goals.
Our overall objective is to efficiently evaluate the efficacy of new agents with high potential to have activity in
osteosarcoma based on target data from our genomic and proteomic profiling both as single agents and in
rational combinations, with the vision of moving effective agents into clinical trials through the Children’s
Oncology Group. We have three specific aims- 1) to select and test agents in vivo against surface targets
identified by comprehensive proteomic profiling of osteosarcoma xenografts and patient tumors; 2) to select and
test agents in vivo against targets identified by comprehensive genomic profiling of osteosarcoma xenografts
and patient tumors; and 3) to perform testing of rationally combined agents based on target, toxicity and efficacy
data of single agents.
Agents from the PPTC pipeline will be selected based on either the proteomic target or genomic alteration being
present in at least a subset of available osteosarcoma PDX models. The agent will be tested in selected cohorts
of low/ high expressing protein target or present/ absent genomic alteration. In cases with multiple models with
target expression, 3-5 mice per model will be used and in cases with few models available, 8-10 mice per model
will be used for control and experiment groups with an overall n per arm per experiment of approximately 30
mice. Standard PPTC procedures will be used for tumor implantation and treatment. Tumor dimensions will be
measured twice a week and response quantified as per standard PPTC definitions of complete response,
maintained complete response, partial response, stable disease and progressive disease. For combination
studies, three potential types of combinations will be considered based on efficacy and toxicity data- a) two
surface protein targeted agents such as two antibody-drug conjugates; 2) two molecularly targeted agents and
3) a surface protein targeted agent and a molecularly targeted agent. Our results will guide the development of
the next generation of clinical trials in osteosarcoma.

Public health relevance
Project Narrative Survival outcomes for children, adolescents and young adults with osteosarcoma, the most common malignant bone tumor in this population have remained stagnant for over 3 decades and new approaches utilizing targeted therapies are needed in improve cure rates. In order to identify targeted therapies with highest potential to have clinical efficacy, a robust osteosarcoma preclinical drug screening program with the capacity to rapidly and efficiently screen numerous agents is needed. We propose to use genomic and proteomic profiling in molecularly characterized osteosarcoma patient-derived xenograft models to guide the selection and testing of targeted agents, including antibody-drug conjugates and inhibitors, in preclinical models of osteosarcoma.